The Influence of Morphosyntactic Network Complexity on Typical and Atypical Language Learning

Project Summary
The proposed project details an innovative line of research that draws on advanced tools from the field of network
science to elucidate typical and atypical language learning mechanisms in adults. Network analysis of natural
language has revealed a number of global structural patterns emerging from relationships (used to construct
network edges) between words (used as network nodes). Informed by the naturally-occurring network
architecture of real-world languages, we will construct miniature artificial languages that display emergent
properties of existing language systems and measure the extent to which these languages are learned by adults
with typical development (TD) and those with developmental language disorder (DLD) (Aim 1). Given that DLD
is often associated with deficits in processing and producing complex morphosyntax, we will concentrate on
networks in which edges between words represent either their co-occurrence in a sentence or overlap in
morphological family (e.g., eater, eating). In Aim 2, we will examine whether language learning deficits in adults
with DLD might be recast as a hyperfocus on local-level information (i.e., “oddball” structures or individual word
frequency) at the expense of the broader architecture of the language learning environment. To strengthen links
between deficits in language learning and expressive language, Aim 3 calls for the network analysis of elicited
speech samples to reveal whether individuals less sensitive to complexity in learning might also display reduced
complexity in their language output. Of individuals diagnosed with receptive and expressive language disorder
in childhood, the vast majority continue to struggle with language impairment in adulthood. Despite a pressing
need for expansion of adult-oriented language interventions, characterization of the full scope of deficits in
individuals with DLD, in addition to their language learning mechanisms beyond childhood, is an understudied
area.

Public health relevance
Project Narrative The proposed project will apply cutting-edge methods from network science to investigate mechanisms of typical and atypical language learning. With a focus on complex grammatical patterns, our work compares learning in young adults with typical development to learning in young adults with expressive and receptive language impairment that has persisted since childhood (Developmental Language Disorder; DLD). A formal characterization of complex pattern sensitivity will inform our understanding of basic mechanisms of language acquisition and may lead to the development of therapeutic interventions tailored to the specific needs of adults with DLD.